Bone Formation and the Immuno-Skeletal Interface

Osteoporosis is endemic in the US and other Western societies and fractures are a serious medical problem
among aging Veterans and their peers in the general population with 1 in 2 females and 1 in 4 males over the
age of 50 projected to suffer an osteoporosis related bone fracture in their lifetimes. Fractures lead to huge
healthcare expenditures, loss of mobility and significant morbidity. Hip fractures almost always require major
surgery and mortality rates are extremely high in aged individuals following surgery, approaching 24% in the
general population and reaching as high as 32% in male veterans. Historically, anti-resorptive drugs (such as
bisphosphonates) have been the mainstay of anti-osteoporosis therapy/fracture prevention and although these
agents stall further bone degeneration and lead to an increase in bone mineral density, they are inefficient at
restoring high quality, remodelled bone and many patients treated with these drugs ultimately still go on to sustain
a fracture. Compliance in taking anti-resorptive agents is furthermore extremely poor with multiple large
population studies conducted in major healthcare systems all reporting abysmal patient compliance with typically
75% of patients discontinuing their anti-resorptive medications within a year of initiation, due to inconvenient
administration schedules, side-effects and costs. Recently, rare but potentially serious complications of long term
anti-resorptive use have led to hysteria among the public and an unprecedented and alarming retreat from
pharmacological fracture prevention therapy is now underway. This has led to a "call for action" by the ASBMR
leadership, however clearly, other pharmacological alternatives are now even more urgently needed. In contrast
to anti-catabolic agents, drugs based on parathyroid hormone (PTH) such as Teriparatide (PTH (1-34)) and
Preotact (PTH (1-84)), are the only FDA approved bone anabolic therapies capable of stimulating bone formation
and reversing bone loss, thus reducing the odds of fracture. Although additional bone anabolic drugs are in
development, potential side-effects have indefinitely delayed final FDA approval of Amgen’s anti-sclerostin
antibody Romosozumab. PTH-based anabolics, like Teriparatide, are thus likely to remain the only available
bone anabolic agents for the near future. Teriparatide however, has significant limitations of its own that have
constrained its wider application, including inconvenient daily injection and rapidly waning efficacy. During the
tenure of this Merit program we made the unexpected discovery that the pharmacological T cell
immunosuppressant Abatacept (CTLA4-Ig), used in the therapy of inflammatory diseases, such as rheumatoid
arthritis, mediates a bone anabolic signal. When Abatacept renders T cells dormant (anergic), it transforms them
into Wnt10b secreting cells. Wnt10b is a ligand for the Wnt-signal transduction pathway, that promotes bone
formation by stimulating differentiation and activity of osteoblasts. Teriparatide itself promotes bone formation in
part by upregulating Wnt10b in T cells. We hypothesized, and demonstrated, that by priming T cells to undergo
anergy, Abatacept is able to amplify the anabolic activity of Teriparatide in mice. As Abatacept alone has more
modest bone anabolic activity than Teriparatide alone, our Merit renewal proposes to investigate methods to
intensify the bone anabolic activity of Abatacept, Teriparatide and Abatacept and Teriparatide together. In Aim
1 we will investigate whether raising basal T cell activation state can amplify the bone anabolic activities of
Abatacept and Teriparatide, alone and in combination, by enhancing the capacity of T cells to secrete enhanced
concentrations of Wnt10b in response to these stimuli. In Aim 2 we will examine if Abatacept and/or Teriparatide
enhance bone anabolic activity in the context of an inflammatory environment such as rheumatoid arthritis, using
the collagen induced arthritis mouse model. Because T cell anergy is dependent on sustained cAMP signalling
and the Wnt10b gene promoter is regulated in part through cAMP response elements (CREs), Aim 3 will examine
the role of cAMP signalling in T cells and Wnt10b generation by anergic T cells.

Public health relevance
Fractures are a serious medical problem among aging Veterans and in the general population with almost 50% of older women and 30% of older men likely to suffer a fracture in their lifetimes. Fractures can be devastating and are associated with crippling disability requiring rehabilitation in up to 75% of individuals with loss of independence and significant decline in quality of life. A 2007 study of elderly veterans by Bass et al., reported that mortality within one year of hip fracture was 18% for women and 32% for men. Economic burden of fracture in the US is projected to reach $25 billion/annum by 2025. As the largest integrated health care system in the US, the VA is on the front lines of fracture treatment and rehabilitation and will have to continue to wrestle with these ever-expanding medical costs. The studies in this application deal with novel mechanisms to promote bone regeneration using pharmacological manipulation to exploit a recently identified quirk in the immune system, capable of promoting new bone formation. Our goal is to improve bone density to prevent fracture.